Interactions between the Gut Microbiome, Intestinal Development and Metabolic Health after Fetal Growth Restriction

PROJECT SUMMARY/ABSTRACT
Fetal growth restriction (FGR) impacts 10-20% of pregnancies worldwide and increases the offspring’s
risk for later development of obesity and type 2 diabetes due to incompletely understood mechanisms. The
focus of this proposal is the nexus of intestinal development and gut microbiome establishment. Gut microbial
composition represents an important and modifiable factor that contributes to postnatal intestinal function
and systemic health and has been understudied in FGR. Our preliminary studies demonstrate impaired
glucose tolerance in adult FGR males after high fat diet challenge and gut microbial dysbiosis into adulthood.
The purpose of this work is to test the reciprocal relationship between the intestine and microbiome in
FGR, and how a microbiome-directed nutritional intervention can impact that relationship. The central
hypothesis is that impaired intestinal and gut microbial development in FGR increases risk for adverse
outcomes which can be mitigated by postnatal dietary interventions. Aim 1 will use our established mouse
model of FGR to test the function of intestinal stem, goblet, Paneth, and enteroendocrine cells. Organoid
formation and single cell RNA sequencing of ileal and colonic cells will further characterize intestinal
development differences between control and FGR animals. Aim 2 examines whether FGR animals can
sustain transplanted fecal microbiome from control animals, testing for intrinsic defects of microbiome
establishment. Aim 3 tests the ability of early supplementation with human milk oligosaccharide 2’-
fucosyllactose (2’FL) to protect against adverse metabolic outcomes in adult FGR mice. Control and FGR
offspring will be challenged with a high fat diet with or without 2’FL supplementation. At age 24 weeks we will
assess glucose homeostasis, body composition, energy balance, and microbiome composition.
The interdisciplinary approach is innovative as it examines a potential mechanistic role for the gut
microbiome in adverse metabolic outcomes after FGR. The proposal is significant as it addresses a critical and
prevalent clinical problem with high translation potential. The proposed research is translational to human
health as 2’FL has demonstrated safety in infants and known associations with growth and intestinal health.
Complementary to the proposed research plan, a five-year mentored career development training plan has
been devised, incorporating didactic learning in statistical methods and organoids in addition to hands-on
training in bioinformatic analyses, intestinal pathophysiology, intestinal organoids, fecal microbiome transplant,
and evaluation of glucose metabolism. The candidate requires mentorship by a multidisciplinary team and has
assembled a group with expertise in fetal growth restriction, intestinal pathophysiology, microbiome, host-
intestine interactions, and glucose homeostasis. The candidate’s long-term career goal is to become an
independent investigator studying early childhood dietary interventions to improve lifelong after FGR.

Public health relevance
NARRATIVE Infants who experience fetal growth restriction have higher risk of developing obesity, non-alcoholic fatty liver disease and type 2 diabetes in adulthood. Using a mouse model, the proposed research tests for mechanistic roles of intestinal development and the gut microbiome in long-term outcomes and whether a dietary intervention can improve long-term health after fetal growth restriction.